Delta Mississippi Center of Excellence in Maternal Health

PROJECT SUMMARY: OVERALL
Maternal mortality in the United States is higher than in peer nations and has not decreased since 1990.
Beyond mortality, severe maternal mortality impacts far too many women. Not only are these high rates
alarming, but notable racial/ethnic and socioeconomic disparities exist. These inequities are highly regional,
with women living in the rural southeast part of the United States, including the Mississippi Delta, having the
highest rates of maternal mortality and morbidity. Unfortunately, these disparities have proven to be stubbornly
resistant to interventions, necessitating an innovative multifaceted approach focused on community practice,
building trust, and prioritizing patient voices. To meet this need, this proposal aims to establish the JSU-
Mississippi Delta Research Center of Excellence for Maternal Health with the goal of addressing
preventable maternal mortality, decreasing severe maternal morbidity, and promoting maternal health equity in
partnership with the Mississippi Delta community. This research center will conduct two multi-layered research
projects. Research Project 1 will determine the effectiveness of an evidenced-based community health worker
home visiting program grounded in extensive patient and community participation. Research Project 2 will
evaluate the effectiveness of a multilevel and multisectoral communication and health literacy strategy to
increase trust and engagement in postpartum healthcare among women in the Mississippi Delta, with a
specific focus on Black women, their families, and their communities. These research projects both have the
overarching goal of partnering with the community to determine and meet the needs of pregnant and
postpartum women in the Mississippi Delta and address the disparities within maternity care. Supporting the
goals of the research projects, an extensive research training program for early-stage investigators, utilizing
community health partners, will address the interpersonal and structural factors that affect maternal outcomes.
Our Community Partnership Component will ensure a successful, sustained, collaborative working
environment throughout the center with the goal of establishing meaningful and equal community partnerships
throughout the research development process and training. To achieve these objectives, we have brought
together an experienced team with diverse expertise and perspectives, combining knowledge and resources
from Jackson State University, the Mississippi State Department of Health, Six Dimensions (a Mississippi
community-based public health consulting company), the Harvard TH Chan School of Public Health, and
various community partners. By establishing an equal partnership with the community in all parts of the
process – including integration with clinical practices and hospitals, connection with community resources, and
regular input from patients – we envision that this research center will overcome structural and interpersonal
barriers to high-quality, culturally competent maternal care and ultimately improve maternal morbidity and
mortality for women residing in the Mississippi Delta.
1

Public health relevance
PUBLIC HEALTH RELEVANCE This proposal aims to establish the Jackson State University (JSU) - Mississippi Delta Research Center of Excellence for Maternal Health to address preventable maternal mortality, decrease severe maternal morbidity, and promote maternal health equity in partnership with the Mississippi Delta community. This research center will conduct two multi-layered research projects utilizing community health partners, inclusive of an extensive research training program for early-stage investigators, to address the interpersonal and structural factors that affect maternal outcomes. By establishing an equal partnership with the community in all parts of the process, we envision that this research center will overcome structural and interpersonal barriers to high-quality, culturally competent postpartum maternal care and ultimately improve maternal morbidity and mortality for women residing in the Mississippi Delta.